Release of interleukin-1a as a mediator of immune evasion in cancer

PROJECT SUMMARY
Cell death is the primary goal of most cancer therapies, but how different forms of cell death regulate the
immune response and can be combined with immunotherapies is poorly understood. Inducing necrosis or
programmed necrosis are a focus for cancer therapies as these induce loss of membrane integrity and the
subsequent release of intracellular molecules that stimulate an inflammatory response, collectively known as
alarmins or damage-associated molecular patterns. Surprisingly however, we have found in preliminary studies
that programmed necrosis promotes tumor growth and reduces survival in preclinical models by recruiting
myeloid cells and creating an immune suppressive microenvironment. These changes are similar to those
observed during response to the chemotherapeutic paclitaxel, and are driven by release of the cytokine
interleukin-1 alpha. Here we seek to understand how interleukin-1 alpha release alters the immune response
during therapy, how release is controlled by the ability of different therapies to activate cell death pathways,
and if targeting interleukin-1 alpha can promote response to standard-of-care therapeutics.

Public health relevance
PROJECT NARRATIVE Here we propose to understand how cell death pathways alter the immune response to chemotherapy, focusing on the role of the nuclear alarmin interleukin-1 alpha in promoting the recruitment of immunosuppressive myeloid cells into tumors.